Molecular and Circuit Pathogenesis of Alcohol Use Disorders

Molecular and Circuit Pathogenesis of Alcohol Use Disorder
This NIAAA Alcohol Research Center (ARC) Grant is the catalytic element that integrates a large group of
investigators across the University of North Carolina at Chapel Hill (UNC). The UNC School of Medicine Bowles
Center for Alcohol Studies (BCAS), provides a foundation of administrative support and dedicated space for
alcohol research. The UNC ARC fosters interdisciplinary collaborative research on alcohol use disorders, alcohol
abuse and the impact of alcohol on health and disease - exactly the goal of an NIAAA ARC. The ARC has
facilitated the growth and development of UNC into an outstanding alcohol research university, among the best
in the world. Research and education have always centered on a theme of molecular pathogenesis of alcohol
use disorders. This renewal focuses on alcohol-induced circuit pathology that underlies addiction. Ultimately, our
guiding hypothesis is that alcohol-induced molecular signaling disruption and dysregulation of neural circuitry
drives pathological behaviors and is thus the key cause of all alcohol-related pathology.
This fifth renewal of the UNC ARC continues an emphasis on alcohol use disorder pathogenesis, integrating
new leadership of existing faculty and new team members to investigate changes in neural circuits and molecular
signaling in models of AUD as well as humans. The scope of these studies addresses the critical neurobiological
changes leading to alcohol-related pathologies, i.e., the mechanisms leading to heavy chronic drinking. The
ARC integrates studies of multiple signaling systems and neurocircuits that each focus on specific mechanisms
within and across brain regions. A range of molecular mechanisms that drive these circuit alterations will be
explored, particularly excitatory/inhibitory (E/I) balance - a theme that will be interrogated at multiple levels of
analysis in all the brain circuits. Some Research Components also include the translational endpoint, functional
magnetic resonance imaging (fMRI) connectivity of pathological circuits in the Scientific Resource Core. This
approach is expected to increase discovery, improve models and gain strength from common assessments
across preclinical models to the ARC human studies.
This ARC renewal continues to be the catalytic element that integrates a broad group of investigators, pairing
senior and junior faculty within ARC components that promote discovery across the BCAS and UNC. This
proposal connects 11 independently funded faculty across multiple themes and projects. The ARC Information
Dissemination Core informs practicing health professionals, professional and college students as well as youth
through specific alcohol curricula for each group to have the greatest impact on health.
In summary, the ARC will conduct, promote, support, and mentor research on the pathogenesis of alcohol use
disorders and educate broad groups of the public, including health professionals, families, college students and
youth in North Carolina on the causes and prevention of these disorders.

Public health relevance
Narrative The University of North Carolina Alcohol Research Center will conduct, promote, support, and mentor research on the molecular and circuit pathogenesis of alcohol use disorders and educate broad groups of the public, including health professionals, families, college students and youth in North Carolina, on the causes and prevention of these disorders.